Enhancing the Capacity of Pediatric Primary Care Providers: A Pilot Trial of Anxiety Action Plan

Anxiety disorders in youth are: 1) the most prevalent psychiatric illnesses, 2) associated with severe disability,
and 3) considered gateway disorders--as they predict a broad range of adult psychiatric and functional
problems. Despite the high prevalence and impairment, less than half of anxious youth receive mental health
services and access to evidenced-based interventions lags far behind that of less common psychiatric
illnesses, such as attention deficit hyperactivity disorder. This application addresses this mental health service
gap and responds to NIH’s priorities in PAR-MH-21-131: Pilot Effectiveness Trials for Treatment, Preventive
and Services Interventions (R34) aimed at testing interventions with previous efficacy in community settings
using novel service delivery methods. Specifically, we propose to refine and assess the feasibility of the
Anxiety Action Plan (AxAP), a brief intervention to reduce pediatric anxiety, delivered by primary care providers
(PCPs; defined here as nurse practitioners, physician assistants, and/or pediatricians) in community pediatric
primary care clinics. Primary care settings are ideal for addressing pediatric anxiety specifically because: 1)
prevalence rates of excessive anxiety are high in primary care (approximately 10-20%), 2) over 90% of anxious
youth report physical complaints (e.g., stomach aches) and are “frequent flyers” in primary care settings, 3)
children with, compared to without, medical conditions treated by PCPs are more likely to have elevated
anxiety, and 4) PCPs are often the first and only health professional children visit. This proposal builds on the
PI’s development and feasibility pilot work with PCPs conducted as part of the NIMH-funded Center for Mental
Health in Pediatric Primary Care and with school nurses as part of a Department of Education grant. The
AxAP, modeled after the Asthma Action Plan familiar to PCPs, is based on the core element of cognitive
behavioral therapy for anxiety (i.e., behavioral exposure), was designed to fit within the short primary care visit
(20-30 minutes), can be delivered virtually, is brief (1-4 sessions), and can be billed for as an office visit.
Uniquely, and in stark contrast to co-location or integrated models, the goal of the AxAP is to enhance the
capacity of PCPs to identify and intervene with anxious youth, which will enhance access to care in general
and especially in locations with few mental health specialists. The proposal also incorporates several innovative
features including pilot tests of measures to conduct: 1) a cost-benefit analysis of the AxAP and 2) an
examination of theory-based target mechanisms at the child, parent and PCP levels. If results of this study are
positive, findings would support a large effectiveness trial using an intervention that is ready for dissemination
and that could significantly improve clinical care for anxious youth, enhance the capacity of PCPs to identify
and reduce anxiety, and lower personal and economic costs associated with pediatric anxiety.

Public health relevance
Pediatric anxiety disorders are common and severely impair the lives of youth and their families; yet less than half of anxious youth receive any intervention. The goal of this application is to reduce this mental health service gap by enhancing the capacity of primary care providers (PCPs) to identify and reduce anxiety, by refining, assessing the feasibility, and conducting a pilot randomized controlled trial of the Anxiety Action Plan, a brief PCP-delivered intervention to reduce pediatric anxiety.